New eras of catalysis: Towards the development of pseudotransition metal organocatalysts for metal-free cross-coupling transformations

Transition-metal catalyzed cross-coupling transformations are indispensable to pharmaceutical development
and medicinal chemistry, allowing access to innumerable bond connections in extremely complex molecular
settings. Despite its power, continued reliance on transition-metal catalysis poses many challenges. For
example, a most pressing challenge in pharmaceutical synthesis is the extreme cost associated with the noble
metals that form these precious, high-powered catalysts (e.g., Ru, Rh, Pd, Pt, and Ir). Furthermore, transition-
metals are treated with strict regulation due to their elemental toxicity, imparting significant cost in the upstream
synthetic stages of delivering a drug to the marketplace. Finally, continued reliance on transition-metal catalysis
is unsustainable, threatened by the rapid depletion of raw materials at known global deposits and consistent
supply-chain disruptions. Thus, the development of alternative strategies for mild and general bond formation is
necessary for continued productivity in pharmaceutical and medicinal chemistry.
Organocatalysis is an attractive surrogate to traditional transition-metal catalysis, leveraging readily
accessible, inexpensive, and practical small molecules as catalysts. The identification of an organocatalyst with
the ability to mimic the behavior of a transition-metal catalyst forms an ideal approach; a priori, such a strategy
would be “plug and play,” invoking only a change in catalyst identity while preserving the nature of cross-coupling
partners traditionally utilized in cross-coupling chemistry. If successful, this approach would address each of the
challenges previously enumerated.
The goal of this proposal is to design, synthesize, and develop a series of “pseudometal” organocatalysts
to facilitate a vast array of catalytic cross-coupling transformations. These catalysts are termed pseudometal to
reflect their ability to mimic the classical bond-breaking and bond-forming behavior of transition-metal catalysts.
Specifically, this research plan details the development of ortho-dithioquinones as pseudometal organocatalysts,
guided by principles of rational design, structure-activity-relationships, computational modeling, and hypothesis-
driven experimentation. Our preliminary computational results direct us to ortho-dithioquinones due to the neutral
Gibbs free energies predicted for oxidative insertion of these scaffolds into several s-bond types. In this research,
rigorous mechanistic and characterization studies will profile the key principles inherent to organocatalyst
speciation and the associated elementary steps, featuring stoichiometric studies, linear free-energy relationship
analyses, and catalytic intermediate characterization. Guided by a rich mechanistic understanding, we will
examine the synthetic capabilities of these organocatalysts through a series of cross-coupling transformations,
including examples of C–N, C–O, C–SF5, and N–CF3 bond formation. Overall, this research will establish a new
paradigm for sustainable, accessible cross-coupling chemistry, and will significantly contribute to medical
research, pharmaceutical development, and fundamental knowledge in organic synthesis.

Public health relevance
Project Narrative The proposed research is aimed toward the development of ortho-dithioquinones as pseudometal organocatalysts, entirely metal-free small molecules capable of mimicking the redox processes and elementary steps of traditional transition-metal catalysts. The proposed strategy will not only provide a suite of organocatalysts to serve as complements and alternatives to transition-metal catalysts, but also it will provide new opportunities for the discovery of fundamental new reactivity in bond forming processes and for the development of novel methodologies capable of unlocking previously dormant catalytic pathways. Ultimately, this research will facilitate the expansion of sustainable and economical organocatalytic reactions as alternatives to traditional transition-metal catalysis, thereby enhancing the productivity of medicinal chemistry campaigns, increasing accessibility in pharmaceutical development and proliferation, and advancing fundamental aspirations in the pursuit of human health.